Molecular genetic basis of sex-specific differentiation of germ cells

SUMMARY
The oocyte, when fertilized has the capacity to generate every cell in an organism. Efforts to understand
and harness the reprogramming potential of this “mother of all stem cells” gave rise to today's stem cell
research field. Despite their unique developmental potential, oocytes are highly specialized and differentiated
cells. A key step in oocyte development is the transition from a mitotic germline stem cell that in most
animals is specified prior to sexual differentiation to a meiotic germ cell that develops as an oocyte in
females or sperm in males. Development of the oocyte is a prolonged developmental time-period
characterized by highly conserved periods of meiotic activity, arrest, and substantial oocyte growth and
maturation to yield a fertilizable egg. Before the first meiotic division the oocyte stops producing new RNAs.
Consequently, control of programs vital to egg production and fertility rely heavily on regulation by proteins,
called RNA binding proteins, that bind to RNAs and regulate their activity.
Reproductive success relies on proper establishment and maintenance of sexual identity. Defects in
germ cell differentiation can lead to infertility or germ cell tumors. Identifying RNA binding protein
targets, and determining how they act in oocyte development is essential to fill the large gaps in our
understanding of the mechanisms and molecular pathways that preserve female sex identity of the germ
cells and fertility. Our long- term goal is to determine the mechanisms that regulate sex-specific programing
of germ cells. We utilize the zebrafish, a powerful vertebrate genetic system to examine the mechanisms and
identify genes that are crucial for successful fertility, maintenance of germ cell identity and ovarian reserve, and
thus may define new molecular pathways that, when defective, can result in reduced fertility, premature
ovarian insufficiency, polycystic ovary syndrome, or cancers in humans. In this proposal, mechanisms
regulating sex-specific differentiation of germ cells and fertility will be tested using a combination of genetic
loss of function and over expression approaches.

Public health relevance
NARRATIVE Germline stem cells are essential for fertility. Our long-term goal is to understand the mechanisms that regulate specification and maintenance of the germline. The goal of this proposal is to investigate the function and contribution of conserved genes to plasticity and differentiation of germ cells, which has implications for premature ovarian insufficiency, polycystic ovary syndrome, fertility, and cancer.